Administration-Resource for Molecular Imaging Agents in Precision Medicine

The Administrative Core of the Resource for Molecular Imaging Agents in Precision Medicine will
coordinate all activities of the NCBIB including provision of a liaison to the Collaborative and Service Projects
to assure their sustained productivity. This Core will be housed within the organizational structure of the Division
of Nuclear Medicine and Molecular Imaging within the Department of Radiology. This Core will also be
responsible for organizing oversight, namely, meetings of the Internal and External Scientific Advisory
Committees. In collaboration with staff in the Training and Dissemination Core It will be the focal point for
organization of scientific meetings and retreats related to the TR&Ds in a continual effort to maintain their
cohesion and sense of purpose.
The PI of this Core, Dr. Pomper, is experienced in the synthesis and development of molecular imaging agents
for a variety of modalities and is conversant in both basic research and clinical medicine, particularly radiology
and nuclear medicine. He has substantial experience in running NIH-funded programs in parallel and in
collaboration with investigators external to Johns Hopkins. Dr. Pomper will be responsible for routine operation
of this Core in close collaboration with the PIs of the four TR&Ds, which will form an Executive Committee of the
BTRC. The PIs of the TR&Ds work in close proximity on the Broadway Campus of Johns Hopkins Medical
Institutions, facilitating face-to-face meetings, which will occur formally on a quarterly basis. As these PIs are
already collaborating on other projects, informal meetings will occur much more frequently if not on a daily basis.
The Executive Committee will turn to the IAC and EAC for further input on an annual basis, each, offset by a six
month interval. The IAC and EAC will be comprised of local and extramural experts, respectively, in the synthesis,
characterization, validation and implementation of molecular imaging agents for a variety of modalities. As the
biological theme of the NCBIB is relationships between cancer, inflammation and immunity, we will have at
least one IAC and one EAC member dedicated to immunology at all times. The EAC has one member who
serves as a patient advocate. Minutes of the EAC meetings will be provided in annual progress reports to NIBIB.
There are many other informal aspects of oversight at Johns Hopkins with which the Administrative Core will
interface, including the Radioactive Drug Research Committee, the Animal Care and Use Committee, the
Clinical Research Office of the Sidney Kimmel Comprehensive Cancer Center and the Institutional Review
Board. The Administrative Core will support the TR&Ds in development and maintenance of relevant animal
and human protocols, where appropriate.
Financial aspects of the NCBIB will be closely monitored through the Administrative Core. There is strong
institutional support, including financial support, for the NCBIB as described in the letters from the Director of
Radiology and the CEO of D&D Pharmatech.